Project 1: Investigation of immune and stromal factors that promote prostate adenocarcinoma progression and castration response

Project Summary/Abstract
Large scale sequencing efforts have comprehensively defined the genomic landscape of localized and
metastatic prostate cancer, yielding an improved understanding of drivers of disease initiation and progression
and greater insight into mechanisms of resistance to androgen receptor (AR) pathway inhibition. One limitation
of this “tumor cell focused” genomic approach is a relative lack of insight into how the tumor microenvironment
(TME) plays a role. However, recent advances in single cell sequencing technologies have opened the door to
comprehensively examine tumor/microenvironment interactions with unprecedented precision. Our group has
embraced this approach: initially to characterize epithelial/stromal interactions in the normal prostate, and now
to delineate tumor cell/microenvironment interactions in genetically engineered mouse models (GEMMs) of
prostate cancer. These studies reveal a striking level of complexity. We have not only defined previously
unknown subpopulations of luminal epithelial and stromal cells in the normal prostate gland, but also we have
shown how these populations change/evolve during progression to invasive disease and in response to AR
pathway inhibition (i.e. castration). In addition, our preliminary data showing that depletion of tumor-infiltrating
immune cells delays disease progression eliminates any doubt that these TME changes are secondary
phenomena.
Based on these findings, we hypothesize that the prostate TME (immune cells and stromal cells) plays a
crucial role in disease progression. We will explore this hypothesis through three synergistic specific aims that:
(i) address the mechanism by which tumor infiltrating immune cells enhance tumor progression; (ii) elucidate
how changes in Wnt pathway signaling in prostate stroma promote invasion by tumor epithelium; and (iii)
determine whether/how the response of prostate tumors to AR pathway inhibition is influenced by inhibition of
AR in the surrounding TME cells. We have extensive experience with the GEMMs, tissue recombination assays
and organoid culture that will be used to address these questions. We also have a strong track record of
translating laboratory findings to the clinic, which will ensure the human relevance of our findings. Finally, this
project is highly integrated with all other components of this program project: through collaborative interactions
with the Shen lab in analyzing the transition to neuroendocrine disease, with the Abate-Shen lab in studies of
Wnt pathway signaling in bone metastasis, with Core A for analysis of human tissue samples and with Core B
for statistical support and data management.

Public health relevance
Project Narrative Our proposed studies of the tumor microenvironment in prostate cancer are based on accumulating evidence that immune cells and stromal cells surrounding the tumor provide important signals that can accelerate progression of the disease. Furthermore, the primary treatment for advanced prostate cancer (hormone therapy) affects these immune and stromal cells in addition to the tumor cells, and we have limited insight into how these unintended treatments effects influence clinical outcome. The work in this Project will provide greater clarity on how the tumor microenvironment enhances tumor growth and help pave the way to better treatments, including improved use of hormone therapy.